Effects of Auditory Neuropathy and Cochlear Hearing Loss on Speech Perception

PROJECT SUMMARY
Access to high-quality auditory input is crucial for successful speech and language development. Hearing losses
caused by Auditory Neuropathy (AN) or Cochlear Hearing Loss (C-HL) degrade the auditory signal, but in
different ways. After accounting for audibility, listeners with C-HL often exhibit normal or near-normal temporal
resolution accompanied by impaired spectral resolution. Many listeners with AN display poor temporal resolution.
This is important because differences in a listener’s access to timing and frequency cues can affect sensitivity to
acoustic-phonetic cues that support both language acquisition and speech perception. The proposed research
will evaluate the short-term and long-term effects of degraded spectral and temporal resolution on speech
perception and phonological awareness in children with AN and C-HL compared to children with normal hearing.
Evaluation will involve psychophysical tests of spectral and temporal resolution as well as speech perception for
words in which recognition relies on either vowel or consonant perception. The training plan outlined in this
fellowship proposal includes skill development in the areas of research design, signal detection, speech
perception, language development, statistical modeling, professional network development, and ethical conduct
of research. The combined resources of The University of North Carolina and Boys Town National Research
Hospital provide unique opportunities for technical training and career development, in addition to unparalleled
models of the successful integration of clinical and research endeavors.

Public health relevance
PROJECT NARRATIVE Access to high-quality auditory input is crucial to the development of spoken language in children with hearing loss. Additional understanding of the perceptual consequences of Auditory Neuropathy and Cochlear Hearing Loss in school-age children is a first step to developing future audiologic treatments and optimizing best practices for maximizing speech perception outcomes in these populations. The proposed project aims to evaluate spectral and temporal resolution abilities and their relationship to phonological processing and speech perception in children with Auditory Neuropathy and Cochlear Hearing Loss.